1/2 The Partnership for Native American Cancer Prevention

American Indians/Alaska Natives (AIAN) are disproportionately impacted by the burden of cancer. Compared
to other racial and ethnic groups in the United States (US), AIAN individuals face higher rates of many cancers,
later stages at diagnosis, worse outcomes after diagnosis, and lower rates of cancer survival. The Partnership
for Native American Cancer Prevention (NACP), a 21-year collaboration between Northern Arizona University
(NAU) and the University of Arizona Cancer Center (UACC), has made impactful strides that successfully
address the causal factors that drive AIAN cancer inequities. NACP has had a significant positive impact on
the pipeline of AIAN individuals seeking careers related to cancer health research, including the training of
Native investigators poised to be leaders in this field. NACP has been a driver of institutional change at both
NAU and UACC by fostering an increase in cancer research capacity at NAU and health disparity-focused
research at UACC and by elevating both institutions’ commitments to serving AIAN students and communities.
NACP has built a strong foundation of relationships with tribal communities, governments, and other partners,
based on trust and respect, and this is resulting in an acceleration of the positive impacts driven by NACP’s
activities, both present and future. NACP is poised to realize past investments while sustaining current
relationships and expanding interactions to additional tribal communities in Arizona. The NACP remains
committed to its core goals of reducing the burden of cancer within AIAN populations through research and
community engagement, growing the number of AIAN investigators participating in the cancer research
workforce, and increasing the total number of investigators focused on cancer health disparities within Native
Arizona communities. While these overall goals remain consistent, NACP is introducing an operational
framework to systematically incorporate Indigenous perspectives as a core reference to guide and thread
together its work. NACP will embrace the ‘two-eyed seeing’ paradigm, which seeks to “see from one eye with
the strengths of Indigenous knowledges and ways of knowing, and from the other eye with the strengths of
Western knowledges and ways of knowing, and to use both of these eyes together for the benefit of all.”
Aim 1. To engage in bidirectional communication grounded in the principle of reciprocity with our AIAN
community partners to promote best practices with respect to cancer health and to develop research priorities
and programs that address AI cancer health disparities.
Aim 2. To grow the pipeline of cancer-focused Indigenous researchers and health care professionals through
educational and training programs tailored to high school, undergraduates, graduate students, junior
investigators, and early-stage investigators.
Aim 3. Conduct impactful cancer disparity focused research that is informed by and inclusive of tribal
community priorities and concerns.

Public health relevance
The Partnership for Native American Cancer Prevention (NACP) will embrace the ‘two-eyed seeing’ paradigm, which seeks to “see from one eye with the strengths of Indigenous knowledges and ways of knowing, and from the other eye with the strengths of Western knowledges and ways of knowing, and to use both of these eyes together for the benefit of all.” The overarching goals and objectives of the NACP are to reduce the cancer burden within the Arizona Native American population through research and community engagement; expand the number of Native American investigators working in cancer research; and increase the total number of investigators focused on Native American cancer health equity.